Spatiotemporal Dynamics of Collective Antibiotic Resistance in Microbial Communities

Project Summary
Antibiotic resistance is among the most serious threats to global public health in the 21st century. Bacteria
have a remarkable ability to evolve resistance to antibiotics, regardless of their class or mechanism of
action. Unfortunately, the pace of drug discovery lags far behind the rapid pace of emerging resistance.
As a result, there is an urgent need to understand how bacteria respond to antibiotics on multiple length
scales, ranging from the molecular level to the scale of entire microbial communities, in hopes of prolonging
the efficacy of current drugs or uncovering new potential therapies. In addition, it is critical to understand
how antibiotic resistance determinants evolve and spread in microbial populations. A number of recent
studies suggest that the response of cellular communities to antibiotics is often a collective phenomenon,
indicating that a detailed characterization of molecular mechanisms—while essential—may not be
sufficient to predict large-scale microbial behavior and evolution. In this proposal, we outline an integrated
research program aimed at understanding how collective interactions in bacterial communities impact the
dynamics and evolution of antibiotic resistance across multiple length scales, ranging from the large-scale
behavior of spatially extended communities to the single-cell architecture of biofilms. If successful, our
work will uncover new quantitative principles of microbial ecology, provide experimental model systems for
testing predictions of evolutionary theory, and clarify the role of community dynamics in shaping the
bacterial response to antibiotics. These results will enrich our understanding of how cellular cooperation is
disseminated in spatially complex environments, with potential implications for basic evolutionary biology
as well as other health-related fields, such as cancer biology, where multi-cellular coordination may
underlie disease. In the long term, the findings may even open the door to innovative therapies aimed at
destabilizing community structure in bacterial infections.

Public health relevance
Project Narrative Antibiotics represent a landmark achievement of medical science and have saved countless lives. Unfortunately, their efficacy is rapidly declining due to the emergence of drug-resistant pathogens. This study combines mathematical tools from physics with quantitative experiments on pathogenic bacteria to investigate how the spatial arrangement of bacteria in microbial communities contributes to—and is shaped by—the spread of resistance to widely-used antibiotics.